Characterizing the interaction between human and vector behaviors to enhance the impact of malaria control interventions in Uganda

PROJECT SUMMARY/ABSTRACT
Great progress was made in reducing the burden of malaria in sub-Saharan Africa from 2000 to 2015, with a
majority of the cases averted attributed to the scale up of vector control with tools like insecticide-treated bednets.
More recently, however, progress has stalled, and even reversed course in some high burden countries. The
World Health Organization now recommends local tailoring of malaria control interventions to enhance their
effectiveness. Few national malaria control programs have on hand malaria surveillance systems capable of
producing the high-quality data necessary to tailor control interventions at the sub-national level. This creates an
urgent public health need for enhanced malaria surveillance that can guide planning of control strategies by
linking clinical outcomes to control interventions. Long-lasting insecticide-treated bednets (LLINs), the most
widely used tool for malaria prevention, no longer seem as effective as they once were, likely as a result of
resistance to pyrethroid-class insecticides and changes in the vector behaviors and species composition. Fur-
thermore, human behaviors, such as lower rates of LLIN use and more time spent outdoors, may also be reduc-
ing the effectiveness of vector control tools. Ultimately, it is the interactions between humans and vectors that
determine the effectiveness of vector control. As a result, this proposal focuses on biological and behavioral
factors that modulate interactions between humans and malaria vectors in the context of vector control interven-
tions. Our central hypothesis is that there are gaps in protection despite the use of existing vector control tools
(e.g. LLINs) which can only be elucidated by integrating human and vector monitoring data. Our proposed ap-
proach will be to add rigorous human behavioral and entomological monitoring to our existing malaria surveil-
lance network in 38 sites across Uganda. This network provides longitudinal estimates of clinical outcomes in-
cluding malaria incidence and parasite prevalence from communities in target areas around government-run
health facilities. Working in the context of “real-life” implementation of vector control interventions (e.g. LLIN
distribution campaigns), our primary goal will be to link measures of human-vector interaction to epidemiological
outcomes across geographic and transmission settings. Achieving this goal will enable us to answer fundamental
questions about why malaria persists in the face of current control strategies and provide practical options for
policy makers seeking evidence-based, targeted, interventions. In addition, this surveillance system will be ide-
ally positioned to evaluate the impact of new vector-oriented interventions as they are implemented in the future.
This proposal represents a unique opportunity to provide both actionable data for policymakers and also gener-
ate fundamental insights for the many other countries throughout the world that rely on vector control to fight
malaria. Our long term goal is to provide insights into how vector control tools affect clinical outcomes through
reducing human-vector interaction and make progress in finding better ways to prevent malaria in the future.

Public health relevance
PROJECT NARRATIVE The proposed research is highly relevant to global public health because progress in controlling malaria transmission has stalled or worsened in many high burden African countries and it now seems apparent that our traditional one-size-fits-all approach to vector control is insufficient to turn the tide. In line with NIAID initiatives seeking to understand vector-host interactions in malaria transmission, we propose to establish a rigorous and comprehensive malaria surveillance system in Uganda that links clinical outcomes with vector and human behavioral monitoring. This system will provide malaria control programs in Uganda and elsewhere with new insights into which vector control tools work and why, helping us to regain the initiative in malaria control.